Population Sciences Program

The Population Science (PS) Program's overall goal is to reduce and prevent morbidity and mortality associated with cancer and its treatment, particularly through identification of genetic and modifiable factors that may influence adverse outcomes. To address this goal, our research is focused around four themes, each of which includes research along the cancer continuum ranging from cancer etiology to cancer treatment outcomes: Nutrition and Chemoprevention; Molecular Epidemiology of Cancer Risk and Prognosis; Cancer Health Disparities; and Tobacco Epidemiology and Translation into Policy. Molecular Epidemiology and Cancer Health Disparities particularly are critical and broadly considered concepts in all themes. The Program members seek to address cancer-related problems that are important to the community that we serve, with outreach, education and interventions to reduce cancer risk and morbidity within our catchment area. The PS program is co-led by Drs. Christine Ambrosone and James Marshall, who together facilitate research in discovery, to identify genetic and environmental causes of cancer and its outcomes; prevention interventions, particularly among those at greatest risk; translation and dissemination to the community; and to ultimately impact policy, particularly related to tobacco. PS seeks to translate basic and clinical science findings to human populations, integrating basic science with cancer epidemiology. PS members include scientists with expertise in each of these areas. Program themes have matured and expanded over the last funding cycle, enhanced by receipt of a number of ROl grants supporting molecular epidemiology of cancer risk and prognosis, disparities research, including POl and U54 grants, ROl and U01-funded dietary interventions, and continued NCI and FDA support for tobacco research. The PS Program is comprised of 22 members from 7 RPCI departments (Cancer Prevention and Control, Health Behavior, Medicine, Surgical Oncology, Urology, and Dentistry), whose total peer-reviewed funding is $17.4M (NCI funding $12M) and total funding is $22.6M. This compares favorably to $11M peer reviewed/$17M total funding at the time of the last renewal. Of the 4g9 publications generated over the last funding cycle, 28% are intra-programmatic and 15% are inter-programmatic; 40 publications were in journals with an Impact Factor > 10.

Public health relevance
The PS program conducts research to prevent cancer and its precursors, and to reduce morbidity and mortality associated with cancer and its treatment outcomes. Interventions among community and high-risk populations translate findings from the laboratory and observational studies to the community, with a focus on underserved populations in our catchment area.